Daily vitamin D for sickle-cell respiratory complications: Phase 2: IND107584 - 11/14/17

7.0 Project Summary/Abstract
This Phase 2 clinical trial (ViDAS-2) will determine if daily oral vitamin D for children with sickle-
cell disease can reduce the risk of respiratory complications, the leading cause of morbidity and
mortality. Our previous ViDAS-1 clinical trial provided evidence that monthly bolus oral vitamin
D3 supplementation in children with sickle cell disease reduced the annual rate of respiratory
complications by more than 50% (P=0.0005) but only after a year of treatment and with no
significant difference between vitamin D3 given as standard- (12,000 IU/mo) or high- (100,000
IU/mo) dose therapy. The scientific premise of the proposed clinical trial is that increased
circulating concentrations of vitamin D3, the parent compound, are needed for the anti-infective
and immunomodulatory effects of supplementation. With monthly bolus oral vitamin D3,
circulating vitamin D3 is cleared from the circulation within days. In the earlier ViDAS-1 clinical
trial of monthly bolus oral vitamin D3, neither the standard- nor high-dose treatments would
produce sustained increases in circulating vitamin D3, potentially explaining both the uniformity
of response to the two treatments and the delay in reducing the rates of respiratory events. With
monthly bolus oral dosing, vitamin D3 slowly accumulates in adipose tissue and would only
gradually increase circulating vitamin D3 concentrations. Our hypothesis is that daily oral vitamin
D3 will rapidly increase circulating vitamin D3 and reduce the rate of respiratory complications by
50% or more within the first year of treatment. We propose a 2-year controlled, double-masked,
randomized Phase 2 clinical trial comparing the efficacy in reducing the rate of respiratory
events in sickle-cell disease of daily oral vitamin D3 (3,333 IU/d) with monthly bolus oral vitamin
D3, (100,000 IU/mo) as a control. Baseline concentrations of 25-hydroxyvitamin D in our
population (mean ~14 ng/mL) guide the choice of the high-dose daily treatment and are too low
to permit inclusion of a placebo control. This Phase 2 clinical trial has three specific aims:
(1) to determine whether daily oral vitamin D3 (3,333 IU/d) given to children and adolescents with
sickle-cell disease, compared to monthly bolus oral vitamin D3, (100,000 IU/mo) will more
rapidly reduce the rate of respiratory events, defined as respiratory infections, exacerbations
of asthma, and episodes of the acute chest syndrome;
(2) to evaluate the effects of daily oral vitamin D3 on pulmonary function; and
(3) to examine the effects of daily oral vitamin D3 on immune function, using biomarkers of
systemic inflammation and of T-cell effector and regulatory function..

Public health relevance
8.0 Project Narrative This Phase 2 clinical trial (ViDAS-2) will determine if daily oral vitamin D for children with sickle- cell disease can reduce the risk of respiratory complications, the leading cause of morbidity and mortality. The results could show that daily oral vitamin D is more effective than monthly bolus dosing in producing the anti-infective and immunomodulatory effects of supplementation. Daily oral vitamin D could offer a simple, low-cost intervention to help avert serious respiratory complications in sickle-cell disease that could lead to important reductions in morbidity and death in children with sickling disorders.